Mechanisms of Dietary Restriction in Drosophila

Abstract For a broad range of taxonomically diverse organisms, nutrient availability acts as a powerful modulator of health and longevity through molecular mechanisms that are largely unknown. In mammals, longevity through diet restriction is accompanied by a broad-spectrum improvement in health during aging. We and others have used genetic and environmental manipulations in invertebrate model systems to establish that nutrient- mediated longevity is a regulated response that activates specific neurons and that involves neuroendocrine systems targeting conserved pathways in peripheral tissues. These target pathways have since been manipulated in mammalian systems to improve longevity or other health-related phenotypes, which reinforces the effectiveness of simple model systems for aging research. Nevertheless, the development of successful human interventions requires a much better mechanistic understanding of how neuronal inputs are integrated and how critical metabolic processes implement the changes that underlie the effects of diet-restriction. In this renewal, we build upon the results from the parent award to continue our dissection of the molecular mechanisms of DR. First, neuronal control of the DR response will be examined by elucidating the mechanisms through which a newly described gene that we call ponchik modulates obesity, feeding behavior, and longevity. We will also take advantage of a completed genetic screen to identify new modulators of dietary restriction that act exclusively in the fly brain. Second, we have discovered that the transsulfuration pathway (TSP), which controls the metabolism of sulfur-containing amino acids, actively promotes survival and metabolic homeostasis in response to nutritional and hormonal signals. We will test a model involving the TSP as an energy sensor that affects protein synthesis, xenobiotic and antioxidative responses, and the production of key signaling molecules that promote health and longevity, specifically under conditions of dietary restriction. The contributions of this project are two-fold. First, we will continue to elucidate the basic principles of how aging is controlled by the nervous system. Second, we will determine how the evolutionarily conserved process of transsulfuration promotes lifespan and influences energy balance. These contributions are significant because understanding the molecular details of how nutrient- and energy-sensitive neural circuits direct changes in peripheral tissues to alter lipid metabolism, behavior, and overall lifespan in a complex organism will illuminate basic principles of aging that can be applied to develop novel intervention strategies in human aging.

Public health relevance
Project Narrative Dietary restriction is the most potent way to extend lifespan and ameliorate aging-related disease in mammals. Our studies will identify how diet orchestrates changes in the brain and throughout different tissues in the fruit fly, Drosophila melanogaster, to influence health and aging. Because the focus of our work is on biological processes that are evolutionarily conserved, our discoveries will illuminate mammalian studies in these areas and foster new ideas for medical intervention. __SpecificAimsTextDelimiter__ Dietary restriction (DR; the limitation of food availability without malnutrition) has effectively increased the lifespan of nearly every species to which it has been applied. In mammals, enhanced longevity is accompanied byabroad-spectrumimprovementinhealthduringaging(WeindruchandWalford1988;Bargeretal.2003;Lon- go and Finch 2003; Contestabile 2009). Work from our lab during the previous funding period has contributed to a model of DR that invokes the activation of specific neurons, including sensory neurons, and that involves neuroendocrine responses that target conserved pathways in peripheral tissues (Bishop and Guarente 2007a; Libert and Pletcher 2007; Libert et al. 2007). Some of the target processes identified from this work, including respiration, xenobiotic detoxification, lipid metabolism, and protein homeostasis (McElwee et al. 2004; Bishop and Guarente 2007b; Pletcher et al. 2007; Steffen et al. 2008; Wang et al. 2008), have since been manipulated in mammalian systems to improve longevity or other health-related phenotypes (e.g., Harrison et al. 2009; Selman et al. 2009). Indeed, translation of discoveries from simple models to more medically relevant systems has been surprisingly effective. Nevertheless, the development of successful human interventions requires a much better mechanistic understanding of how neuronal inputs are integrated and how critical metabolic processes imple- ment the changes that underlie the effects of DR. The overarching goal of our research program is to develop a complete map of the molecular basis of the DR response in Drosophila. The objectives of this application build on discoveries from the previous funding period and are designed to test a model involving neural control of DR enacted through modulation of specific meta- bolic pathways in target tissues. In particular, we have discovered a novel neuronal modulator of lifespan and an evolutionarily conserved pathway that is required for the effects of DR on fly aging and physiology. Once the integrative nature of the DR response is worked out in simple model systems, and regulatory and effector systems are identified, innovative interventions can be developed to capture the beneficial effects of DR on hu- man health and longevity. We therefore propose to identify new neuronal components of the DR response and to dissect a new DR effector pathway in flies by pursuing the following twoAims: T r r . A large- scalegeneticscreendesignedtoidentifygenesthatregulateenergybalanceanddiet-dependentphysi- ology revealed a new gene, which we named ponchik, as well as 130 other candidate genes. Aim 1a: Test the hypothesis that ponchik couples diet-dependent feeding behavior and energy balance with lifespan. ponchik is expressed in the brain in a diet-dependent manner, and it modulates feeding behavior, en- ergy balance, and lifespan. We will determine its role in aging and the DR response. Aim 1b: Identify new neuronal genes that mediate diet-dependent phenotypes. Using neuron-specific RNAi, we willtestthe130candidategenesthatwereselectedfromourmutantscreentoidentifythosethatmedi- ate DR phenotypes solely through their expression in neurons. r . Wehavediscoveredthatthetranssulfurationpathway(TSP)isapotentmodulatoroflifespanand physiology; upregulation is both required for DR longevity and sufficient to increase lifespan. Aim 2a:Ascertain the tissue-specific requirements by which TSP activity is necessary and/or sufficient for the DR response. We will test our working hypothesis that the TSP acts as an energy sensor in key tissues to become activated under DR to promote lifespan. Aim 2b: Determine the effector pathways through which the TSP modulates DR in Drosophila. We will test a model whereby upregulation of the TSP promotes longevity through its affect on protein synthesis, xenobiotic and antioxidative responses, and the production of key signaling molecules. The proposed research proposed is expected to identify important mechanisms that define how nutrient- and energy-sensitive neural circuits direct changes in peripheral tissues to alter lipid metabolism, behavior, and overall lifespan. By efficiently identifying specific molecules and genetic pathways that link diet composition with adult longevity and physiology in Drosophila, our studies will illuminate basic principles concerning how neuronal, endocrine, and metabolic networks may coordinate homologous processes in mammals.